Smartphone based custom-fit and low-cost hearing aids manufacturing system

Project Summary:
We propose in this SBIR effort to create an accessible, low-cost, and customized hearing aid
manufacturing system that leverages smartphone-based 3D ear imaging, automated shell generation,
and efficient 3D printing combined with modular electronic integration. Hearing loss is the third most
prevalent chronic health condition facing seniors. Untreated hearing loss has been shown to lead to
physical, social, emotional, and psychological problems. Unfortunately, fewer than 20 percent of those
with hearing loss who require intervention and treatment seek help for their condition. Reasons for this
grim situation are expensive hearing aid cost, ineffective hearing aid shell fitting optimization process,
and inadequate centers or offices especially in poor and underserved communities. These have in fact
generated significant barriers in affordability, adoption, and accessibility for hearing aid sufferers.
The proposed solution will have the following impact and significance: Effectively reducing
custom-fit hearing aid cost through a mobile 3D imaging framework; Better fitting and comfort for
improved compliance; Better user experience through non-invasive 3D ear imaging; Greatly increasing
the accessibility on custom-fit OTC hearing aids through the gateway of smartphones; and making
localized custom-fit hearing aid production possible for better and more accessible care.
Hearing loss is a public health issue and is among the leading public health concerns especially
for the increasing aging population. In 2020, 55 percent of all adults with hearing loss were 70 or older.
In 2060, that rate will jump to 67 percent. Before seeking a hearing aid, most hearing aid users had lived
with hearing loss for more than 10 years and their impairment had progressed to moderate-to-severe
levels. Undoubtedly, the development of a low cost and ubiquitous mobile platform-based and custom-fit
hearing aid shell optimization and rapid prototyping method will have significant impact on the elderlies
especially for the low- and middle-income sufferers.

Public health relevance
Project Narrative The proposed mobile three-dimensional app based solution to be developed under this SBIR project will lead to an exciting mobile platform-based custom-fit solution known which significantly lowers the cost barrier, vastly simplifies the hearing aid fitting process, and improves the access to the low-cost hearing aid care. The streamlined system leaps beyond the traditional custom-fit hearing aid production process. The unique data acquisition and optimization framework has many advantages over existing practice in the industry. Global hearing aid market is over $10.23 billion and growing with projected annual growth rate of 8.1%. We foresee the proposed solution will have a reasonably large market share in this rapidly growing multi-billion- dollar industry. In addition, the proposed solution can also pave the way for the creation of optimally fitting audio devices for the next generation of “wearable” computers and smartphones.